AMINISTRATIVE CORE

The UCSF Brain Tumor SPORE proposal has 4 overall specific objectives: 1) to identify factors that contribute to the likelihood of surviving brain cancer; 2) to identify spectroscopic, non-invasively derived imaging parameters and linked tissue biomarkers that can help predict recurrence and outcome in patients with low grade glioma; 3) to develop improved therapies for pediatric brain tumors harboring BRAF mutations; and 4) to improve the immunotherapy of brain cancer. The Administrative Core of the UCSF Brain Tumor SPORE has been created to supervise the activities of the UCSF Brain Tumor SPORE and to provide fiscal management, administrative support, and the framework by which researchers can communicate and interact. The aims of the Core are: 1. To evaluate research progress. The Administrative Core, through the SPORE Executive Committee, the SPORE Steering Committee, and the SPORE External Advisory Board, will be responsible for evaluating the progress of projects and making decisions regarding the continuation/replacement of projects. 2. To provide fiscal management. The Administrative Core will distribute funds from the SPORE Award, the Career Development and Developmental Research Programs, SPORE Supplement Awards, and discretionary funds provided by the institution. The Administrative Core will also be responsible for the timely reporting of finances to Project Leaders and the SPORE PI/co-Pls. 3. To provide administrative support. The Administrative Core will be responsible for the daily operations of the SPORE, for the preparation of SPORE-related manuscripts, and for communications with NIH. 4. To facilitate communication between SPORE investigators. The Administrative Core will be responsible for the scheduling of all meetings, seminar series, and retreats, and for the distribution of the notices inviting participation in the Career Development Program and the Developmental Research Program. 5. To assist in compliance. The Administrative Core will be responsible for assuring compliance and scientific integrity of all components of the SPORE. The Administrative Core will be used by all Projects and Cores in the SPORE.

Public health relevance
RELEVANCE (See instructions): Despite the best efforts of neurosurgeons and neuro-oncologists, both the incidence and mortality rates of brain cancer have remained stable over the past 20 years and in 2009 alone, over 12,000 individuals died from brain cancer. The work described in this SPORE application is intended to increase our understanding of this disease, as well as to apply what we learn in the clinical setting, and in the process to improve the lives of individuals with brain cancer.